Establishing Walking-related Digital Biomarkers in Rare Childhood Onset Progressive Neuromuscular Disorders

PROJECT SUMMARY
Individuals with childhood onset, genetically determined neuromuscular disorders (NMD) experience progressive
neuromuscular degeneration resulting in weakness that affects ambulatory function. Genetic testing and
consensus-derived diagnosis guidelines have led to an increasing prevalence of neuromuscular diseases
approaching other more common neurological conditions. Recent therapeutic approaches in Duchenne
muscular dystrophy (DMD) and spinal muscular atrophy (SMA) have resulted in disease modifying therapies
commercially available or in clinical trials with the best outcomes with early treatment. While results from novel
drug therapies are promising, symptoms of weakness and impaired function persists. Patients report changes in
motor function in real-world settings, but these changes often elude standard in-clinic examinations. There is a
compelling need to develop more sensitive, quantitative assessments that focus on ambulatory function in real-
life settings. Digital mobility outcomes (DMOs) use wearable technology for continuous remote monitoring in a
person’s own environment.
Consumer-grade activity trackers monitor healthy and clinical cohorts, but with limited accuracy. Research grade
trackers and foot-worn gait monitoring devices measure mobility-related volume (step count, distance, duration
of walking bouts, etc.), but can only capture a minimal set of stride-by-stride real-life gait parameters (e.g., stride
time, length, velocity) and they cannot measure kinetic parameters. We argue that the modest accuracy and
granularity of current wearable devices hamper the objective characterization of subtle but clinically meaningful
changes. Our recent findings suggest that novel machine-learning (ML)-based abstraction models may map
noisy signals from foot-worn sensors (namely, instrumented insoles developed by the project team) into accurate
and clinically relevant spatiotemporal and kinetic gait parameters. These gait parameters derived from
instrumented insoles, which we refer to as digital mobility outcomes (DMOs), may serve as functional biomarkers
to detect changes in real world function. The purpose of this research is twofold: (1) to identify disease-specific
walking-related digital biomarkers of disease severity, and (2) to determine the insole-derived DMOs that are
most sensitive to longitudinal changes in ambulatory function and best able to predict 12-month changes in
ambulatory function in DMD and SMA.

Public health relevance
PROJECT NARRATIVE Recent therapeutic approaches for individuals with neuromuscular disorders (NMD) have resulted in disease modifying therapies but benefits reported by patients, experienced in real-world settings, often elude the standard in-clinic examination. Emerging wearable devices allow for ubiquitous monitoring of physical mobility, but their widespread use in clinical applications is currently hampered by their moderate granularity and accuracy. This research aims to implement novel foot-worn devices that can accurately measure stride-by-stride spatiotemporal and kinetic gait parameters, which can be used as sensitive digital mobility outcomes (DMO) to reflect real-world ambulatory function in individuals with childhood onset NMD.